Determining the molecular basis of chemosensory behaviors in mosquito-borne filarial nematode parasites

Project Summary
During infection and transmission, the larvae of mosquito-borne ﬁlarial nematode parasites perform patterned
migrations, likely using a variety of sensory modalities to navigate the hostile environment of host barriers and
immune attack. Migrations are coordinated with developmental time points in the mosquito vector and deﬁnitive
mammalian host, and aberrant migrations result in transmission failure. Control of diseases caused by ﬁlarial
worm infections, such as lymphatic ﬁlariasis (LF) in humans or heartworm disease in companion animals, has
been hampered by a dearth of available antiﬁlarials, and current control strategies through mass preventative
chemotherapy are susceptible to loss of drug efﬁcacy. Parasite migrations may be vulnerable to therapeutic inter-
vention or strategies for vector-based control, but advances are limited by a lack of knowledge of the molecular
receptors and pathways that mediate intra-host sensory processes. Filarial worms such as Brugia malayi, an eti-
ological agent of LF, and Diroﬁlaria immitis, the canine heartworm, express nematode-speciﬁc G protein-coupled
receptors (chemoreceptors) in amphid sensory organs, and expression is patterned throughout the life cycle
in accordance with non-uniform sensory needs. However, a lack of scalable behavioral assays has prevented
the investigation of ﬁlarial worm chemosensory behaviors and the functional annotation of putative chemosen-
sory receptors. To ﬁll this knowledge gap, this project will (1) develop new higher throughput behavioral assays
using advanced microdevices, microﬂuidics, and high-content imaging, (2) identify host-derived cues that elicit
chemosensory behaviors, and (3) functionally characterize chemoreceptors expressed during migratory time
points. While other parasitic nematodes have large datasets of behavioral responses to host-derived cues, ﬁlar-
ial worms lack this comparative data due to the difﬁculty of performing chemotaxis experiments in vitro. Aim 1
of this project will develop innovative higher throughput behavioral assays that are optimized for multiple larval
stages. These will be used to screen host-derived cues for attractive or repulsive effects. Aim 2 will functionally
annotate putative chemoreceptors by ﬁrst employing RNA-seq to identify chemoreceptors that are upregulated
during migratory time points. These will then be prioritized for annotation with in vivo functional genomics (RNA
interference) and deorphanization leveraging a novel approach that uses expression of parasite chemoreceptors
in the amphid neurons of C. elegans paired with behavioral assays and assessment of receptor activation by live
calcium imaging of amphid neurons in response to activating cues. The result of this proposal will be (1) new
behavioral assays that are capable of assessing a variety of sensory phenotypes of multiple stages and species
of ﬁlarial worms, (2) a vastly expanded set of host-derived cues that induce chemotaxis of larval ﬁlarial worms,
and (3) the functional characterization and deorphanization of ﬁlarial worm chemoreceptors.

Public health relevance
Project Narrative Mosquito-borne ﬁlarial nematode parasites inﬂict debilitating disease upon tens of millions of the world's most im- poverished people, and disease transmission is dependent upon the unique patterned migrations of worm larvae in mosquitoes and humans. Despite the critical importance of these tissue migrations to disease persistence and pathology, very little is known about the molecular events that govern the sensory processes involved in intra- host parasite migration. The proposed research will develop new techniques to investigate ﬁlarial worm sensory behaviors at the host-parasite interface, and it will functionally characterize sensory receptors and pathways that may be vulnerable to therapeutic intervention.